Genetic determinates of SPI1 expression and activity in human germinal center B cells

PROJECT ABSTRACT
Human B cells are exquisitely sensitive to changes in SPI1, a master transcriptional regulator. Loss- and
gain-of-function SPI1 gene mutations were recently described as causes of agammaglobulinemia and
Waldenström macroglobulinemia. Preliminary data indicates other changes in SPI1 activity/dose may cause
additional clinical phenotypes including common variable immunodeficiency (CVID) and autoimmune
diseases. The long-range goal of the proposed work is to determine SPI1’s full role in human health and
disease(s). Our objective is to establish mechanisms of SPI1 gene regulation in human germinal center B
cells and the consequences of dysregulation. The working hypothesis is that SPI1 has a critical role
throughout B cell development, including germinal center (GC) B cell maturation, and that the culmination of
rare SPI1 coding mutations and common non-coding variants determine disease state. To explore this
hypothesis, we propose the following aims: 1) Identify non-coding elements regulating SPI1 gene
expression in human GC B cells 2) Delineate effects of coding variants in SPI1 on autoregulation and
expression 3) Determine maturational and transcriptional consequences SPI1 LOF and SPI1 GOF
mutations to differentiated B cells. The contribution is significant because SPI1’s role in human GC
responses is unexplored but is clearly affected in several patient groups carrying SPI1 gene mutations. The
proposed work is innovative because we are using only human and human derived cells, including bona
fide tonsillar GC B cells for proposed experiments. We are comprehensively investigating the role of coding
and non-coding DNA on SPI1 regulation using crystallography, NMR, long-read sequencing, prime editors,
base editors, ATAC-, RNA- and ChIP-seq. Finally we are utilizing tonsillar organoids to model the effects of
altered SPI1 dose on GC B cell maturation in human lymphoid follicles.

Public health relevance
PROJECT NARRITIVE: Human B cells are exquisitely sensitive to changes in the transcription factor SPI1. Inherited SPI1 mutations cause various immunological diseases but the mechanism of each is not clear because it is not known how the SPI1 gene is regulated. By determining how the SPI1 gene is controlled, which genetic variants alter SPI1 expression and what B cell stages are most affected by changes in SPI1 dose, we can better understand SPI1’s full role in health and disease.